Voltage Imaging of Astrocyte-Neuron Interactions

ABSTRACT.
Astrocytes control neurotransmission, contribute to a robust blood-brain-barrier (BBB), and metabolically support
neuronal activity. In Alzheimer’s Disease (AD), astrocytes become reactive near A plaques, contribute to
neuroinflammation, and contribute to synaptic and circuit abnormalities. The role that astrocytes play in
controlling synaptic excitation by removing glutamate from the extracellular space is particularly intriguing in AD.
Astrocytes express high levels of excitatory amino acid transporters (EAATs), including GLT1 and GLAST, in
their peripheral processes that bind and remove extracellular glutamate to limit synaptic excitation. EAATs, as
well as other astrocyte proteins, are known to be decreased late in AD progression. Aberrant glutamate signaling
is thought to contribute to AD progression, as evidenced by the clinical use of memantine, a glutamate receptor
antagonist, as an AD therapy, strongly implicating EAATs in the progression of AD. Finally, soluble A inhibits
EAAT function during heightened neuronal activity. Interestingly, we recently showed that neuronal activity
causes astrocyte depolarization, which drives voltage-dependent inhibition of EAAT function to enhance
neuronal activation. In the parent R01, we use astrocyte-expressed genetically encoded voltage indicators
(GEVIs) to optically quantify Vm and showed that neuronal activity depolarizes peripheral astrocyte processes
(PAPs) with synapse-specificity. In this supplement request, we provide preliminary data that during normal aging
astrocytes sporadically lose the expression of GLT1, GLAST, and Kir4.1 and take on a phenotype known as
atypical astrocytes (AtAs). Importantly, AtAs are not a form of reactive astrocytosis. Preliminary data suggests
AtAs are more abundant and occur earlier in the APPNL-G-F mouse model of AD and are seen in the aged human
brain. Here we will test they hypothesis that because AtAs, which lack Kir4.1 and GLT-1, are abundant in the
hippocampus of APPNL-G-F mice, astrocytes experience increased activity-induced depolarization, leading to
exaggerated inhibition of glutamate uptake. This creates a situation in which increased neuronal activity could
drive synergistic voltage-dependent and A-mediated EAAT inhibition in AD. We chose to use the APPNL-G-F
model due to its early onset, overlapping with the normal development of AtAs, without APP overexpression.
Using the APPNL-G-F mice, we will determine: (SA1) “Do hippocampal astrocytes in APPNL-G-F mice show increased
Vm responses to neuronal activity?” and (SA2) “Is activity-dependent inhibition of glutamate uptake enhanced in
the hippocampus of APPNL-G-F mice?“. Both increased activity-induced PAP depolarization and elevated A could
alter activity-induced EAAT inhibition in APPNL-G-F mice. If so, this would position astrocyte-neuron interactions,
K+ and glutamate homeostasis as key players in early AD progression and would motivate enhancing glutamate
and K+ uptake to reduce AD-related pathology. When complete, we will know whether newly discovered changes
in PAP Vm are exaggerated and contribute to aberrant glutamate excitation in APPNL-G-F mice. We will be poised
to leverage these findings to enhance K+ and glutamate homeostasis to prevent pathological excitation in AD.